Administrative Core (AnC)

Abstract: Administrative Core: AC
The AC will play a central role in organizing, integrating, and managing these considerable resources to
maximize the overall productivity of our proposed Chicago Asian RCMAR. This Administrative Core (AC)
includes: 1) recognized experts and leaders in trauma, resilience, and health outcomes research across Asian
populations with strong track records of leadership and mentorship; 2) significant resources through the Rush
University Colleges of Medicine, Nursing, Health Sciences, and Graduate College; 3) a well-designed
mentoring infrastructure to support RCMAR Scholars; 4) support for mentors; and 5) strong and broadband
connections to both practice and policy at local and national levels. The AC leaders, Drs. Dong and Aggarwal,
along with the assembled co-investigators, center faculty, executive committee, and internal and external
advisory committees have extensive experience in successfully conducting research on the Center's themes
through a cultural lens. Leveraged resources and support will come from Chicago- and institution-wide
infrastructure that are substantial and will provide steadfast support in accomplishing our RCMAR mission
(Dean, Provost, President, and CEO).
The AC will establish mechanisms and infrastructure that promote optimal communication, interaction,
collaboration and integration to foster synergistic work across RCMAR Scholars and faculty. The AC will also
ensure that RCMAR Scholars have full access to the time and expertise of the transdisciplinary core faculty,
both individually and in collaborative settings across Chicago institutions. The AC will work with the Executive,
Internal, and External Advisory Committees to integrate translational research through perspectives of
academic, community, state, and national leadership. The AC will provide strong leadership along with the
infrastructure and administrative support needed to orchestrate the Research Education Core (REC),
Measurement and Analysis Core (AnC), and Community Liaison and Recruitment Core (CLRC) into an
integrated center. AC specific aims are: 1) Oversee all Center activities, ensure effective implementation and
fiscal administration and create and sustain mechanisms to enhance integration, coordination and
communication across AC, REC, AnC, and CLRC; 2) Maximize and coordinate use of leveraged resources
and provide mechanisms for interactions between Scholars, researchers, and colleagues; 3) Provide oversight
and support to enhance success of the pilot grant programs, communicate with NIA about pilot studies, ensure
that Scholar's research and mentoring needs are met; 4) Foster interactions and collaborations both at Rush
University, regionally and nationally including sharing of best practice and participation in data-sharing,
methodology and recruitment efforts; 5) Provide systematic, objective and formal evaluation of each core and
the Center in order to establish benchmarks and iteratively improve the Chicago Asian RCMAR.

Public health relevance
Project Narrative: Administrative Core: AC Trauma and resilience and their intersection with health outcomes are understudied in all minority populations, but especially in Asian older adults. The Chicago Asian RCMAR Center will: 1) advance translational research; amongst older Asian Americans 2) nurture future investigators in an environment that is conducive for success; and 3) inform the design of future intervention & prevention strategies for trauma-informed care as well as practice and policy at the local, state, and federal level.